CORE--MORPHOLOGY AND CELLULAR IMAGING

Description (provided by applicant): The Cellular and Molecular Imaging Facility Core provides equipment, training, services, and consulting expertise related to the analysis of normal and abnormal morphology at the whole animal, organ, cell, subcellular, and molecular levels. State-of-the-art techniques available to all CEHS investigators are: cellular imaging with confocal laser scanning microscopy and quantitative ion analysis, histopathology, immunohistochemistry and light, epifluorescence, transmission and scanning electron microscopy, and isolation of lung cells and tissues. The Core personnel actively assist investigators to develop new methodologies for imaging, and cellular quantitation. At times, when services needed go beyond the resources of the Core, The Core facilitates collaboration with other campus groups and/or institutions for Center investigators. The objective is to provide the highest quality tools for histologic and cellular analysis, diagnostic interpretation, and consultative expertise for the evaluation of mechanisms of toxicant action. The main objectives of the Cellular and Molecular Imaging Facility Core are to: (1) provide service in imaging to scientists affiliated with the Center; (2) act as a resource by providing information on the latest approaches and techniques; and (3) offer training to graduate students, postdoctoral, and junior scientists in using the imaging instruments.